Implementing a patient navigation intervention across a health system to address treatment entry inequities

Project Summary/Abstract
Opioid agonist treatment (OAT) is protective against overdose, yet less than 20% of people with opioid use
disorder (OUD) engage in such treatment. Hospital utilization is high among people with OUD and can be a
‘reachable moment’ to initiate OAT. However, most hospitals lack the capacity to follow up with patients after
discharge. Theory-based, empirically supported patient navigator (PN) interventions following hospital
discharge reduce inequities in accessing community-based OAT by helping patients navigate complex systems
of care. However, challenges persist in implementing PN interventions on a wide scale, as they require
coordination across institutions, data sharing, dedicated personnel, and community resources. This is
especially true in settings that reach diverse, resource-challenged communities. To bring these interventions to
scale, strategies are needed to assess factors that influence PN implementation in hospitals to increase
feasibility, reach, and sustainability. Testing innovative implementation strategies for PN interventions has the
potential for significant impact, as it will demonstrate implementation success of an intervention that can
address the opioid epidemic in real-world settings and close the research-to-practice translation gap. The
proposed study is a type II hybrid implementation-effectiveness trial of Navigation Services To Avoid
Rehospitalization (NavSTAR). Our research team showed in a single-site randomized trial with 400
participants that NavSTAR significantly increased OAT entry, reduced readmissions, and was highly cost-
effective compared to treatment as usual. The present study will test an Implementation Facilitation (IF)
strategy following Proctor’s conceptual model using an external facilitator and an internal local clinical
champion to provide training, resources, and performance feedback to implement NavSTAR in four hospitals.
We hypothesize that engaging stakeholders (including patients, clinicians, and community leaders) in an IF
strategy will create and test an implementation process that is feasible, acceptable, and effective in expanding
access to OAT post-discharge. The R61 phase will conduct process mapping to identify existing hospital
workflow and then refine an IF strategy through sequential pilot trials at 4 hospital sites in preparation for the
R33 phase. The team’s NavSTAR operations manual will be adapted to the sites to train the existing staff. R61
milestones include the creation of an implementation toolkit and data sharing agreements. During the R33
phase, we will conduct a type II hybrid-implementation-effectiveness trial (N=720) of NavSTAR using a
randomized stepped-wedge design with augmented inverse probability weighting to compare outcomes pre-
and post-implementation. This study will develop an effective IF strategy to increase the reach and
sustainability of NavSTAR and provide a path to scale-up this intervention to address the opioid epidemic.

Public health relevance
Project Narrative Patient Navigation (PN) interventions following hospitalization can mitigate the significant racial, ethnic, socioeconomic, and geographic disparities that persist when accessing treatment - which contribute to the opioid overdose epidemic. However, challenges persist in implementing PN interventions on a wide scale, as they require coordination across institutions, data sharing, personnel, and regional awareness, especially in settings that reach diverse, resource-challenged communities. This hybrid Type II implementation- effectiveness study will systematically find solutions to these significant implementation barriers by engaging an evidence-based implementation facilitation strategy to develop a hospital system-wide PN protocol that can be scaled up to address opioid use disorder treatment linkage and continuity after hospitalization.